Advancing gastric cancer precision medicine in Latinos through patient-derived modeling

PROJECT SUMMARY/ASTRACT
Gastric cancer (GC) is a leading cause of cancer incidence, mortality, and survival disparities in Latinos, the
largest and youngest U.S. minority and the largest racial/ethnic group in the UCaTS states of California and
Texas. When compared to non-Latino whites (NLW), GC incidence and mortality is ~>2-fold higher in Latinos.
Indeed, among all cancer types, GC is the malignancy with the highest disparity ratio among Latinos. Latinas
have a 2.6-fold higher GC mortality compared to NLW women, while Latino men are at a 2.1.-fold higher risk of
dying when diagnosed with GC relative to NLW men. Despite this high GC burden and the fact that most gastric
tumors carry “druggable” mutations, only three targeted therapies have been approved for GC. As part of our
ongoing UCaMP (University of California Minority Patient-Derived Xenograft Development and Trial) minority-
focused PDTC, we have shown that most GC molecular subtypes in Latinos carry druggable mutations and that
they are particularly enriched in tumors carrying multiple and complex genome alterations in PI3K/AKT/mTOR,
CDK, WNT, and RTK/RAS pathway genes. Over half of Latino tumors have mutations in multiple genes in these
and other pathways. Because ~35% of Latino GCs have dual/concurrent PI3K and CDK pathway alterations, we
will initially focus our studies using these two pathways but will aim to expand to other type of tumors with co-
mutated pathways. This project aims to develop a body of pre-clinical and mechanistic data that will help address
Latino GC disparities, and that will be necessary for the establishment of minority-focused clinical trials of
targeted therapies. As part of our NCI-funded UCaMP PDTC, our UCaTS research team has already successfully
created 55 patient-derived GC models, with ~60% of the models from Latinos. We have also shown that Latino
PDXs are responsive to dual treatments with PI3K inhibitors (PI3Ki) and CDK inhibitors (CDKi) and have
identified a model with PIK3CA hotspot mutations with an exquisite response to the PIK3i taselisib. Using our
UCaTS infrastructure of six comprehensive cancer centers in California and Texas, our goal in the next cycle of
our U54 study is to establish an additional 60 GC models, all from minorities, and to work on the following aims:
i) To evaluate GC patient-derived models for identifying efficacious drug combination in tumors with multiple
pathway alterations; ii) To understand the mechanisms of response to taselisib in PIK3CA mutant tumors and;
iii) To evaluate the effect of genetic ancestry in response to chemotherapies and targeted therapies in Latinos.
Through these studies we will develop effective drug combinations that can be rapidly translated into minority-
focused clinical trials for gastric cancer patients.

Public health relevance
PROJECT 1 NARRATIVE The University of California and University of Texas Southwestern Diversity Patient-Derived Xenograft (PDX) Development and Trial Center leverages the collective strengths of six NCI- Comprehensive Cancer Centers to create minority patient cancer models and characterize targeted treatment responses to stomach and lung tumors.Thisprojectaddressesagastriccancer disparity-focusedresearchproblemusingPDXmodels. Through UCaTS activities, we expect to extend our large repository to facilitate the discover of new therapies that could impact vulnerable racial and ethnic minority cancer patients.